Study of individual variability in acupuncture and placebo analgesia

DESCRIPTION (provided by applicant): Just as patient response to pharmacotherapy can vary, it has long been known that some patients respond to acupuncture and placebo treatment much better than others. Despite advances in this field, the sources of individual variability in responses to acupuncture and placebo treatment are still poorly understood. This career development proposal requests support to develop skills to investigate the sources and underlying mechanisms of this variability. To achieve above goal, the candidate has designed two studies. Experiment 1 will be a behavioral study to investigate the analgesic effect produced by acupuncture and placebo treatment and will initiate an exploratory investigation of the influence of genetic factors on acupuncture and placebo analgesia. Experiment 2 will employ functional Magnetic Resonance Imaging (fMRI) to investigate the different brain networks involved in good and poor responses to acupuncture and placebo treatment. The cumulative results of these studies will elucidate the sources of variability in responses to acupuncture and placebo treatment and thereby increase the understanding of the underlying mechanisms involved. Most importantly, these attempts to distinguish the specific action of acupuncture from placebo will advance the understanding of how acupuncture is different from placebo treatment, a challenge that has been become a significant barrier to the advancement of acupuncture research. This award will provide the candidate, who is trained in both alternative medicine and biomedical science and has research experience in pain, acupuncture, placebo and cognition, with specific training in: 1) genetics;2) advanced statistical analysis;3) MR imaging and analysis;and 4) psychometric measurement. Gaining skill in each of these areas is critical to the candidate's long-term goal of becoming an independent investigator with a focus on the studies of acupuncture and placebo treatment. The rigorous training proposed integrates strong didactics and multidisciplinary expertise to teach the candidate how to synthesize information from diverse fields and apply it to the study of acupuncture and acupuncture mechanisms. This integrated program of training and research will yield new tools for studying acupuncture and placebo treatment and provide the candidate with the skills needed to achieve independence in a highly complex field.